BK Channels of Hair Cells

DESCRIPTION (provided by applicant): The proposal seeks to bring a molecular understanding of how large conductance calcium activated potassium (BK) channels, which are important for hearing affect hair cell function using mouse and chicken hair cells as a model system. The channels consist of the Slo protein and a variable number of associated proteins The proposal seeks to determine how BK channels are localized at the basolateral surface of hair cells. In particular the proposal seeks to ascertain how Slo trafficking in hair cells occur ad tests the hypothesis that Slo in hair cells uses the basolateral secretory pathway in polarized epithelial cells. The role of phosphorylation and associated proteins in bringing about basolateral sorting will be explored. The project will also determine how splicing, phosphorylation and Slo associated proteins affect BK kinetics attempting to relate these changes to those in native hair cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposal seeks to bring a molecular understanding of the role large conductance calcium activated potassium (BK) channels play in hair cell function. These channels have been shown to be crucial for setting a hair cells receptor potential allowing these cells to respond to sustained bundle displacements with graded receptor potentials. The channels consist of the Slo protein and a variable number of associated proteins. Using mouse and chicken hair cells as a model system, we hope to understand the molecular basis of its localization to the base of hair cells. The project will also determine how splicing, phosphorylation and Slo associated proteins affect BK kinetics attempting to relate these changes to those in chicken hair cells, where these properties change along the tonotopic axis. As such the chick epithelium is a well defined crucible that will help bring about an understanding of BK channel function, which is important not only for the understanding of hair cell physiology, but also for understanding myriad other diseases such as hypertension and epilepsy in which BK kinetics play a critical role.